Impact of ALS-linked mutations on the structure, dynamics and function of profilin-1

MASSI/ BOSCO – ABSTRACT
Profilin-1 (PFN1) is a 15kDa actin-binding protein that plays a critical role in regulating cytoskeletal dynamics.
In order to promote actin polymerization in cells, PFN1-bound actin must bind and synergize with formin
proteins. In 2012, we identified mutations in PFN1 that cause the uniformly lethal neurodegenerative disease
amyotrophic lateral sclerosis (ALS), also known as Lou Gehrig’s disease. Defects in cytoskeletal dynamics and
trafficking were already implicated in ALS pathogenesis, however the mechanism(s) by which ALS-linked
proteins disrupt these processes is poorly understood. Many in the field predicted that ALS-linked mutations in
PFN1 would abrogate the binding of PFN1 to other cytoskeletal proteins, such as actin and/or members of the
formin family of proteins. However, rather unexpectedly, our extensive preliminary data show the opposite.
ALS-linked PFN1 (ALS-PFN1) exhibits enhanced binding affinity for select formin proteins in cells and in vitro.
Further, ALS-PFN1 causes formins to become hyperactivated, leading to accelerated and greater actin
polymerization in cells. Our previous biochemical analyses demonstrated that ALS-PFN1 variants are severely
destabilized and prone to aggregate. However, the overall three-dimensional x-ray structures of PFN1 mutants
are very similar to WT PFN1. Therefore, we hypothesize that altered protein dynamics caused by ALS-
mutations account for our observed phenotypes with respect to formin binding, actin polymerization
and PFN1 aggregation. To test this hypothesis, Drs. Francesca Massi and Daryl Bosco have formed a multi-
disciplinary, collaborative project that combines molecular dynamics (MD), NMR, fluorescence spectroscopy
and cell biology to study the interactions of PFN1 with both formins and actin at atomistic resolution. Indeed,
our novel preliminary MD simulations indicate that ALS-linked mutations perturb a network of residues within
PFN1 that contact both actin and formin. Further, our extensive preliminary NMR data reveal PFN1 residues
near the formin-binding interface are affected by actin binding, and that ALS-linked mutations perturb the
intrinsic dynamics of PFN1. Collectively, our preliminary data provide a strong premise that altered protein
dynamics of ALS-PFN1 contributes to dysregulated actin polymerization and protein aggregation, which are
both involved in ALS pathogenesis. Our proposal builds upon our exciting preliminary data to rigorously
characterize the dynamics and mechanism(s) of binding between PFN1, actin and formin. These approaches
are highly innovative in the context of studying actin dynamics, and are ideal for probing the actin-PFN1-formin
ternary complex, for which little is known at atomistic resolution. These studies are expected to have a
significant and broad impact on neurodegenerative disease research, as well as on our fundamental
understanding of actin dynamics.

Public health relevance
MASSI/ BOSCO – NARRATIVE Mutations in profilin-1 (PFN1), an actin binding protein, cause the fatal neurodegenerative disease amyotrophic lateral sclerosis (ALS) through an unknown mechanism. Using complementary biophysical and cell biology approaches, we will rigorously test the hypothesis that ALS mutations perturb the dynamics, protein-binding interactions, and solubility of PFN1 in a manner that contributes to ALS pathogenesis.